Developing, Implementing and Supporting NCI Clinical Trials and the National Cancer Trials Network (NCTN) in Breast Cancer and Developmental Therapeutics- A 5 Year Plan

Dr. Ciara O’Sullivan is a medical oncologist focusing on clinical and translational research in breast cancer
(BC) and developmental therapeutics. Her research has been supported by an American Society of Clinical
Oncology Career Development Award and intramural funding at Mayo Clinic (MC). She develops and conducts
clinical trials designed to test new drugs and overcome drug resistance, predominantly in endocrine resistant
and HER2-positive (HER2+) BC. Another focus is individualizing systemic treatment for early stage HER2+
BC. She is a member of the Alliance Breast Committee and the MC Institutional Review Board (IRB). She
led/is leading 17 NCI sponsored trials and three multisite investigator-initiated trials. Specifically, she is study
chair of an FDA registration trial, CompassHER2 RD (CompassHER2 Trials Examining Escalating and De-
Escalating Therapy in HER2+ Breast Cancer: Optimizing Treatment in Residual Disease [NCT04457596;
A011801]), was PI of ACCRU-BR01, A Phase I/II Trial of Abemaciclib and T-DM1 in Women and Men with
HER2+ Advanced or Metastatic Breast Cancer Who Progressed on Treatment with a Taxane, Trastuzumab
and Pertuzumab (NCT04351230; closed prematurely in 2022) and Co-PI of PROMISE (A Prospective Study to
evaluate the role of Tumor Sequencing in Women Receiving Palbociclib for Advanced Hormone Receptor
(HR)-Positive, Breast Cancer [NCT03281902]). She has developed an initiative with MC patient advocates
which aims to improve BC care through education and patient-centered clinical trials. Dr. O’Sullivan plans to
support the NCTN in the next 5 years through: 1. Continued leadership of A011801, including efforts to
optimize trial accrual; 2. Completion of PROMISE trial objectives; 3. Leadership of active industry sponsored trials at MC, as well as upcoming trials; 4. Continued work with BC patient advocates to develop patient focused clinical trials, addressing barriers to research participation ; 5. Acquiring the necessary skillset to become a leader in the MC and Alliance BC
Disease Groups. Dr. O’Sullivan aims to improve care for BC patients through personalization of systemic
treatment options, investigation of novel therapeutics, development of prognostic and predictive biomarkers
and her BC advocacy endeavors. Her long-term goal is to be an internationally recognized Professor of
Medical Oncology, maintaining a clinical practice with a research focus on endocrine resistance in HR+ BC,
HER2+ BC and BC Advocacy. She is committed to being of service to the NCTN by developing, leading and
recruiting patients to NCI sponsored clinical trials, supporting IRBs and scientific review committees, and
serving on NCI scientific committees. These activities and the derivatives of her proposed work are aligned
with the NCI mission of conducting high-quality cancer research to advance knowledge and improve quantity
and quality of life for all oncology patients.

Public health relevance
Dr. Ciara O’Sullivan’s professional vision is to improve care for breast cancer patients through the personalization of systemic treatment options, investigation of novel therapeutics and the development of prognostic and predictive biomarkers. As an experienced clinical trialist, she is committed to being of continued service to the NCI clinical trials networks through the development of and execution of NCI funded trials, active participation in NCTN-affiliated scientific reviews and monitoring committees, supporting institutional efforts to enhance patient accrual to research studies and ultimately assuming leadership roles at Mayo Clinic and within the Alliance for Clinical Trials in Oncology. Dr. O’Sullivan’s research projects, advocacy efforts and support of the NCTN will significantly improve treatment options for patients with all BC subtypes in the short and long term, which is aligned with the NCI vision of advancing scientific knowledge to improve quality of life and overall life expectancy for these patients.